A New Tool Kit for Whole-Genome Mapping and Complementation in Drosophila

DESCRIPTION (provided by applicant): The ultimate goal of this proposal is to generate, maintain, and distribute a new collection of duplication stocks that covers the entire euchromatic autosomal portion of the Drosophila melanogaster genome. Since this collection will represent a powerful new set of tools that will benefit virtually all Drosophila geneticists, it is likely that there will be a high demand for this resource. Many of the most important advances in our understanding of human development have come from studies using the fruit fly Drosophila melanogaster as an animal model system. Since many parallels exist between Drosophila and mammals in terms of the underlying molecular mechanisms controlling biological processes, knowledge gained from research in Drosophila can be either directly applied or readily adapted to understanding human biology. We propose to generate a new duplication collection that will fill 99.4% of the bases in the gaps of the current molecularly defined Drosophila deletion kit (MDADK) and will offer an average of 10-fold higher resolution. As this duplication kit is based on generating transgenic flies carrying genomic constructs, further manipulation of the same constructs can be performed for downstream functional analysis, including tagging of proteins and structure-function studies. We estimate that between 5,000 and 6,000 transgenic stocks will need to be generated for this collection and will split this project into two phases: Phase I will serve as a proof of principle and cover 8% of the autosomal genome while Phase II will complete the collection. We will: 1. Select and sequence clones to cover all gaps in the molecularly defined autosomal deficiency kit 2. Generate, balance, and maintain 400 transgenic stocks carrying genomic duplications Success of Phase I will not only fill 99.4% of the bases in gaps in the current MDADK, but also set the stage for expanding our effort to generate the complete collection. Harnessing the benefits of new technologies, this collection will be another key addition to the Drosophila research tool kit. As a highly desired resource by most Drosophila geneticists across the world, this collection will offer great utility for the entire Drosophila research community, with applications ranging from genetic fine mapping, genomic rescue, somatic clonal analysis, and genomic tagging. PUBLIC HEALTH RELEVANCE: The main goal of this project is to create a new resource for the Drosophila (a fruit fly) research community that will allow rapid mapping and identification of new genes required for normal development and function. Specifically, we propose to create a large set of transgenic flies that will carry duplications that total approximately 80% of the Drosophila genome but in pieces that represent only a few genes each. Since the vast majority of genes in Drosophila are highly conserved in mammals and often provide critical insights into human gene function, this resource will greatly benefit both basic and applied research. Moreover, this resource will be in high demand for many years to come by the more than 1000 active Drosophila research laboratories around the world and will therefore create a highly marketable and profitable venture.

Public health relevance
The main goal of this project is to create a new resource for the Drosophila (a fruit fly) research community that will allow rapid mapping and identification of new genes required for normal development and function. Specifically, we propose to create a large set of transgenic flies that will carry duplications that total approximately 80% of the Drosophila genome but in pieces that represent only a few genes each. Since the vast majority of genes in Drosophila are highly conserved in mammals and often provide critical insights into human gene function, this resource will greatly benefit both basic and applied research. Moreover, this resource will be in high demand for many years to come by the more than 1000 active Drosophila research laboratories around the world and will therefore create a highly marketable and profitable venture.